PPARdelta receptors and alcohol use phenotypes

Abstract
New neurobiological understanding of and therapeutic targets for alcohol use disorder (AUD) are needed.
Advances in the biology of AUD indicate that lipid signaling is a key regulator of ethanol use and withdrawal
behavior via specialized G-protein coupled membrane receptors, transport proteins, and, more recently,
nuclear transcription factors. PPARs are lipid-sensing transcription factors encoded by 3 genes (PPAR,
PPAR, PPAR) that were identified for their roles in peripheral regulation of fuel homeostasis. PPAR and
PPAR have received intense attention for their anti-addiction-like actions. Yet, the central role of the more
abundantly expressed brain PPARreceptor isotype in the control of compulsive alcohol use behaviors is
entirely unknown. Here, we test the overarching hypothesis that brain peroxisome proliferator-activated
receptors-delta subtype (PPAR) inhibits compulsive ethanol use and negative emotional withdrawal. Studies
use the chronic intermittent ethanol vapor exposure model to elicit escalated and aversion-resistant ethanol
intake and withdrawal anxiety- and irritability-like behavior to yield new translational insights into AUD. We
combine novel brain-penetrant and translatable PPAR agonist (KD3010, T3D-959) and brain-restricted and
site-specific cre/lox conditional PPAR knockouts to test the causal role and central sites of PPARaction in
compulsive-like alcohol use phenotypes. The resulting data and novel genetic and translationally-relevant
pharmacological tools for this understudied PPARδ isotype will lay the groundwork for cell type- and
anatomically-specific mechanistic studies and may lead to interventions for people affected by compulsive
alcohol use and other forms of addiction.

Public health relevance
NARRATIVE This multidisciplinary project combines novel brain-penetrant and translatable PPAR agonists (KD3010, T3D- 959) and conditional cre/lox tools to manipulate PPAR function to test the role of brain PPARδ receptors in compulsive-like AUD phenotypes. Whole-body and brain-restricted transgenic approaches will specifically test the role of brain PPAR receptors in voluntary and aversion-resistant alcohol use as well as withdrawal- associated negative emotional behaviors; the effects of agonists and conditional knockouts on PPAR target gene expression will be studied with regional specificity. Collectively, the resulting data and novel tools for this understudied PPARδ isotype will lay the groundwork for cell type- and anatomically-specific mechanistic studies and may translate to interventions for people affected by AUD and potentially other forms of addiction.